03 Tumor Immunology Program

TUMOR IMMUNOLOGY PROGRAM (TIP): PROJECT SUMMARY
For more than 30 years, the immunology community at Washington University School of Medicine (WUSM) has
had a strong reputation for the significant breadth and depth of its contributions to the field of immunology and
its highly interactive/collaborative nature. A strategic decision was made 20 years ago to promote basic science
research in tumor immunology and establish an infrastructure to facilitate clinical translation of cancer
immunotherapies at Siteman Cancer Center (SCC) and WUSM through the creation of a Tumor Immunology
Program (TIP) as an integral component of the newly forming NCI-designated Comprehensive Cancer Center.
This was a prescient strategic decision, and the number of SCC laboratories currently performing research
related to tumor immunology has increased significantly. Of note, there has been a concomitant increase in the
number of laboratories participating in translational tumor immunology research and the number of investigator-
initiated cancer immunotherapy clinical trials in the current project period. This increase in translational research
has been achieved through the creation of an environment that facilitates and encourages interactions and
collaborations between basic scientists and physician-scientists particularly between SCC research programs,
and where state-of-the-art resources and infrastructure are available to catalyze the translation of these basic
science research findings into novel therapeutic opportunities.
Thus, because of the environment that was established by the SCC, the highly interactive environment now
extends across the basic immunology, tumor immunology, and cancer immunotherapy research communities.
TIP members are conducting research and discovery within four central themes: (1) developing and/or expanding
new models that recapitulate the dynamic interplay between the immune system and cancer; (2) identifying
molecules that serve as targets of the innate and adaptive anti-tumor immune response, and developing
strategies targeting these molecules; (3) defining the roles of immune cells in the tumor microenvironment and
elsewhere in promoting or suppressing anti-tumor immune responses; and (4) translating basic immunologic
research into clinically relevant tests, interventions, and clinical trials.
The TIP has 23 members from six departments at WUSM. The program is supported by $13.7 million in
funding, with $2.91 million from the NCI and $5.10 million from other peer-reviewed funding. During the current
project period, TIP members published 647 manuscripts, with 39% from inter-programmatic collaborations and
21% from intra-programmatic collaborations. During the current project period, TIP members initiated or
supported 256 cancer immunotherapy clinical trials. Although the accruals to these were allocated to SCC’s
disease-focused research programs (STTP, BCRP, and HDMP), TIP members facilitated accrual to these trials
(1,544 interventional treatment accruals, including 501 (32%) to investigator-initiated studies).